Integrative genetics of behavior with high throughput technologies

Identification of functional loci is key to the Maps to Mechanisms to Medicine (M2M2M) paradigm articulated by the International Common Disease Alliance and that has been LNG's focus since 1992. Alcohol Use Disorder (AUD) and Substance Use Disorders (SUDs) are moderately heritable but most of the variance is unexplained. We discovered several functional loci with roles in AUD and SUD via founder populations, people at risk due to exposures, model organisms and intermediate phenotypes closer to gene action. Hypothesis-free omic approaches including GWAS, transcriptomics, methylome and exome sequencing were used to identify targets for functional studies, as well as to understand genetic architecture and transmission. Via GWAS, we found loci for response to alcohol (Lai et al, 2020), AUD (Lai et al, 2021), AUD treatment response (Biernacka, 2021, and alcohol cirrhosis (Schwantes-An et al, 2020, Seth, Whitfield et al, 2021). We implemented an in vitro model of alcohol liver disease via induced hepatocyte-like cells, finding that iHLCs from Alcohol Cirrhosis patients have intrinsic metabolic and transcriptomic disturbances. Via transcriptomics we advanced understanding of glia in SUDs (De Biase, 2017), cirrhosis (Guillot et al, 2021), and developmental effects of nicotine (Jung, 2016). Via transcriptomics we identified pathways, and genes, contributing to intrinsic differences in ovarian steroid response in Premenstrual Dysphoric Disorder and Perimenopausal Depression (Dubey, Mol Psych, 2016; Rudzinskas, Mol Psych, 2020; Li et al, Mol Psych 2021). Via polygenic scores, in the nationally representative NESARCIII sample, we found AUD is cross-inherited with nicotine use disorder whereas inheritance of opioid use disorder is largely independent (Jung et al 2021).
We made progress in identifying functional loci contributing to AUD. OPRM1 Asn40Asp (Bergen et al, 1997) was found to be functional and linked to AUD naltrexone treatment response (Anton et al, 2008). We described a common, functional SNP in the serotonin transporter (Hu et al, 2007) that enhanced understanding of OCD, neuroimaging responses to emotion, and gene x stress interactions. Common HTR2C Ser23Cys (Lappalainen et al, 1999, Okada et al, 2004) and HTR2A Asn452His variants (Ozaki et al, 1997) were found, shown functional, and linked to behavior. We found that a DRD2 promoter variant influences antipsychotic response (Lencz et al, 2006). We traced linkages of functional haplotypes of NPY (Zhu et al, 2008), GCH1 (Tegeder et al, 2006) and DISC1 (Hodgkinson et al, 2004) to emotionality, schizophrenia, and pain. The low expression Neuropeptide Y (NPY) haplotype increased anxiety and emotionality but had stronger effects on molecules (NPY RNA and protein) and brain imaging responses to emotion and pain/stress (Zhou et al, Nature, 2008).
We proposed a multidimensional Addictions Neuroclinical Assessment (Kwako et al, Biol Psych, 2017), recovering a theorized three factor structure in the intramural AUD sample (Kwako et al, AJP, 2019). The imaging genetics paradigm we helped initiate (Heinz et al, 2000; Hariri et al, 2002; Egan et al, 2001; 2003; Zubieta et al, 2003) led to groundbreaking findings. CHRNA5 Asn398, an allele altering nicotine addiction risk, weakened connectivities including a Dorsal Anterior Cingulate/Ventral Striatal circuit predictive of craving (Hong et al, 2010). Clinical subphenotyping enabled linkage of HTR1B to antisocial alcoholism (Lappalainen et al, 1998), serotonin transporter (SLCA4) to anxiety (Mazzanti et al; Hariri et al), BDNF Val66Met to episodic memory (Egan et al, cell, 2003), and GTP cyclohydrolase to chronic pain and experimental pain response (Tegeder et al, 2006). Frontal cognitive deficit is a risk factor in AUD and other diseases. Dopamine generally enhances prefrontal cortical efficiency. Met158, a common COMT variant that leads to four-fold reduction in COMT activity showed an allele-dosage relationship to frontal cognitive function and better cortical efficiency (Egan et al, 2001). The COMT effect on cognition was seen in populations differing in cognitive function: schizophrenia, head injury (Lipsky et al, 2005, 2011), & controls (Malhotra et al, 2002, 2009). We proposed that Met158 has a counter-disadvantage. In two populations Met158 predicted anxiety in women and decreased frontal EEG coherence (Enoch et al, 2003), and Met158 was associated with lower resiliency to pain/stress (Zubieta et al, Science, 2003; Diatchenko et al, 2005, 2006). We extended knowledge of GxE effects of stress related genes such as COMT, NPY, SLC6A4 and SLC6A4 in studies using both behavioral and endocrine outcomes (Lovallo et al 2015, 2016). A functional polymorphism of Fatty Acid Amide Hydrolase (FAAH) predicted placebo response to pain (Pecina et al, 2014).
The Chr 4 GABAA gene cluster was implicated in AUD by family linkage (Long et al, 1998), an effect that appeared anxiety-modulated (Enoch et al, 2006). Another GABAA gene cluster implicated in AUD and alcohol response is on Chr 5 (Radel et al, 2005). GABRA6 has a missense variant associated with alcohol dependence and response to alcohol and diazepam (Iwata et al, 2005). A family linkage scan yielded genome-wide significant linkage of CRF-BP to an AUD-associated EEG trait and this was supported in two populations (Enoch et al, 2008). GWAS of EEG (Hodgkinson et al, PNAS, 2010) in Plains Indians detected genome-wide significant loci (Hodgkinson et al, PNAS 2010). Via GWAS, a schizophrenia risk locus was identified (Lencz et al, Nat Comm, 2013).
Founder, phenotypically extreme, and exposed populations enhance power to detect genes. Our Finnish sample was ascertained from a founder population and via criminal AUD probands. An African American SUD sample revealed GxE of childhood trauma and HTTLPR in suicidality (Roy et al, 2007). Stress and poverty, but not ancestry, predicted SUDs (Ducci et al, 2009). An MAOA VNTR previously linked to dyscontrol via stress interaction was linked to AUD and ASPD in Native American women, half of whom were sexually abused as children (Ducci et al, 2008). A strong interaction between a MAOA VNTR and testosterone on aggression was observed (Sjoberg et al, 2008). We found an HTR2B stop codon that is relatively common in Finns, absent in others, and associated with, but not determinant for, impulsive behavior. The stop codon cosegregated with ASPD and AUD in families and the mouse Htr2b knockout was hyper-aroused and high in novelty response (Bevilacqua et al, Nature, 2010). In animal models, we exome-sequenced the P/NP rat, and discovered a stop codon in metabotropic glutamate receptor 2 (Grm2) that leads to alcohol preference (Zhou et al, 2013). The Grm2 Stop codon is common (0.08) or fixed in parental Wistar rats, depending on source. It leads to uncompensated changes in glutamate function, leading to concerns about rat neuroscience studies in which this stop codon is an uncontrolled variable. As facilitated by a NIDA RFA leading to two U01 grants we identified new loci altering drug preference in rat and Drosophila. We re-discovered the same Grm2 stop codon in a Wistar-derived cocaine model. We found 7 genome wide significant loci accounting for 2/3rds of variance in novelty induced hyperlocomotion, a hyperarousal model predicting drug use (Zhou et al, PNAS, 2019). In the Withdrawal Sensitive/Withdrawal Prone mouse strains, we discovered that genes implicated in epilepsy and neuroexcitability are critical in withdrawal (Zhou et al, Molecular Psychiatry, in press). In Drd2 iMSN partial knockout mice, we found that deficiency of D2 receptor s drives gene networks related to GABA, cAMP, growth and neuroinflammation (Guerri et al, Biol Psych, GoS in press), helping to explain why DRD2 is linked to SUDs in humans.